Enhanced Viro-Immunotherapy for Breast Cancer Brain Metastasis

PROJECT SUMMARY/ABSTRACT
Breast cancer brain metastasis (BCBM) is a major clinical challenge due to their poor response to therapeutic
options. Although the survival rate of breast cancer (BC) patients has improved, the incidence of BCBM is
increasing with recent advance in diagnostic imaging and systemic therapy, and long-term survival rates for
these patients are unacceptably low, urgently calling for new interventions. Oncolytic herpes simplex virus-1
(oHSV) therapy is the most advanced virotherapy as approved by FDA for melanoma in the U.S. and
conditionally for glioblastoma in Japan. However, accumulating clinical data is revealing that oHSV treatment
very weakly induces a systemic anti-tumor immune response which is often offset by the immunosuppressive
tumor microenvironment (TME). Thus, mechanistic identification of the anti-viral resistance is a key to maximize
its therapeutic efficacy. In BCBM, we observed that oHSV therapy induces insulin-like growth factor 2 (IGF2)
expression and secretion, sustaining pro-inflammatory neutrophils in the TME and polarization change to pro-
tumoral neutrophils, hampering the virus propagation and discouraging the development of a strong adaptive
anti-tumoral immune response. Additionally, we found that infiltrated neutrophils by oHSV therapy induces
neutrophil extracellular trap (NET) formation (also called “NETosis”), hampering the therapeutic efficiency of
Viro-Immunotherapy. The overarching goal of this application is to identify the ultimate cause of the poor clinical
response of cancer patients to oHSV therapy, and develop a more effective novel viral immunotherapy for
incurable BCBM. We aim to achieve our goal by deciphering anti-viral resistance mechanism behind oHSV-
induced IGF2/microglia/neutrophil axis, and evaluating therapeutic benefit of IGF2 inhibition and NET
degradation on oHSV therapy. To compromise oHSV-induced IGF2 and its signaling pathways, we generated a
novel IGF2-scavanging oHSV (oHSV-D11mt) and will investigate the therapeutic benefit when combined with
radiation therapy, which has also been hindered by IGF2, neutrophil infiltration and NETosis. We also generated
actin resistant DNase1-expressing oHSV (oHSV-haDNase1) to degrade the NETs for enhanced virus
propagation and access to infiltrating cytotoxic lymphocytes. To test these hypotheses, we will investigate the
contradictory roles of IGF2 in virus clearance and tumor progression (Aim 1), evaluate therapeutic potential of
IGF2-scavenging oHSV-D11mt in combination with radiotherapy (Aim 2), and assess the preclinical efficacy of
NET-mitigating oHSV-haDNase1 (Aim 3). The successful completion of this proposed study is expected to unveil
the role of neutrophil infiltration and NET formation induced by oHSV therapy, and elucidate why oHSV therapy
was not as successful as viral immunotherapy as expected. Therefore, it will accelerate the translation of oHSV
therapy into an efficient and improved treatment modality for the patients with BCBM.

Public health relevance
PROJECT NARRATIVE Breast cancer brain metastasis (BCBM) is associated with deadly outcomes due to limited therapeutic options and poor response, urgently calling for the development of novel therapeutic intervention strategies. We have found that oncolytic herpes simplex virus-1 (oHSV) therapy induces neutrophil infiltration and neutrophil extracellular trap (NET) formation through induction of Insulin-like growth factor-2 (IGF2) expression and secretion into tumor microenvironment (TME), hampering therapeutic efficacy of oHSV. In this proposed research, we will uncover the mechanistic relationship between oHSV-induced IGF2 and oHSV-triggered neutrophil infiltration and NET in BCBM, and characterize the preclinical therapeutic impact of novel IGF2- scavenging oHSV in combination with radiation therapy as well as NET-mitigating oHSV for significant advance of BCBM treatment in the future clinical application.